Administrative Core

Abstract_Administrative Core
The goal of the U19 application “Neural circuit control of fluid and solute clearance during sleep” is to understand
how neural activity drives periarterial CSF inflow and thereby glymphatic waste clearance across time, micro-
macroscopic spatial scales, and species. The program brings together experts in neural computation,
neurovascular coupling, sleep, human neuroimaging, fluid dynamics, and modeling, with a long track record of
productive collaborations.
The Administrative Core will serve as the hub that will coordinate all aspects of the U19 program
functions. Its major goal is to facilitate the exchange of ideas and interactions and to promote the scientific
excellence of the program. The Administrative Core will also oversee that the Data Core shares data within the
U19 program and the outside community. The Core will provide fiscal oversight of all aspects of the program and
implement decisions made by the Internal Review Committee (consisting of the project and core leaders as well
as the program manager) and the External Advisory Board (consisting of 6 internationally recognized scientists
with experience in collaborative studies and data sharing/modeling). One of the Administrative Core’s tasks is to
continuously adjust the use of the Data Science and Viral Tool Development Cores to maximize their support of
the 4 projects. The Administrative Core will also organize and submit the annual progress reports to NIH. The
Core Facility will organize all routine meetings within the program, including core staff meetings, the Internal and
External Advisory Board meetings, the cross-institutional administrative meetings, the annual meeting, and the
site visits. Finally, the Administrative Core will optimize communication between PIs, collaborating faculty, PhD,
MS, and undergraduate students, as well as research staff, to foster a team-based approach to science and
facilitate frequent lab exchanges and opportunities for trainee scientific development.
Altogether, the ambitions of the Administrative Core are to ensure that the overall project runs as
efficiently as possible to reach the research goals and fulfills all requirements of federal and institutional
regulations. Our goals are to understand, for the first time, how coordinated neural activity drives clearance of
fluid and solutes during sleep; and to share with the greater neuroscience community our ideas, data, and
research tools.